Summer Undergraduate Research Program (NEUROSURP) in Neuroscience

Project Summary/Abstract
The current proposal is to support a Summer Undergraduate Research Program in Neuroscience
(NeuroSURP) mentored by Rutgers University research faculty. The program has three primary aims: (1) To
increase student knowledge and appreciation of basic biological research by providing a closely-mentored,
hands-on research experience; (2) To increase student knowledge and interest in pursuing careers in research
through career development and educational activities; (3) To provide continued advice, support and guidance
to program alumni to facilitate post-program career planning and implementation. Twelve undergraduates will
be admitted to our program each year beginning 2024. Special consideration will be given to students from
historically underrepresented minority and disadvantaged backgrounds including Black, Hispanic, Native
American, Pacific Islander, or have physical or mental disabilities, or are from economically and/or socially
disadvantaged backgrounds (collectively referred to as URM) that comprise a deep and diverse pool of
potential future scientists. The research component of the proposed SURP involves hands-on experimentation
in labs with active, nationally recognized and funded research programs in neuroscience with a focus on
neurological disorders at Rutgers University. The infrastructure and general organization of the proposed
program will be based on an existing program that has been in place for 27 years. Students will work on their
own research projects under the close supervision of mentors in their host labs. The proposed SURP is
designed to integrate student research experiences and mentoring with weekly meetings comprising training in
neuroscience, oral and written presentations, critical reading of manuscripts, Responsible Conduct of
Research as well as Rigor and Reproducibility including statistical analysis. In addition, there is a significant
career development component during the weekly meetings in which PhD, MD/PhD and MD guest speakers
discuss their career paths representing academic research, non-academic research as well as research-
related careers. Each year students will present the results of their summer research projects in a symposium
that is open to scientists on campus and members of the general public. In addition, the students submit a
paper on their project in the format of a manuscript and receive feedback from MPIs. Finally, the Co-directors
will maintain close contact with the alumni of our program as we have done for the past 27 years and will
continue to provide them with advice and mentoring related to applying to graduate school and their careers.
The mentors who will be supervising the students study neurological disorders including Alzheimer's,
Parkinson's, multiple sclerosis, autism, traumatic brain injury, spinal cord injury, sensory loss, epilepsy, and
stroke. The multidisciplinary research focus of the faculty mentors on the cellular, molecular, and genetic
processes underlying developmental and degeneration of the nervous system has implications for the etiology,
pathogenesis and progression of neurological disorders.

Public health relevance
Project Narrative Studies on the development, regulation, and maintenance of neural circuits yield insights into mechanisms underlying various neurological disorders. The multidisciplinary training efforts of our faculty working with undergraduate student participants will focus on neurological disorders including Alzheimer's, Parkinson's, autism, multiple sclerosis, traumatic brain injury, spinal cord injury, sensory loss, epilepsy, and stroke, which are of clear relevance to NINDS.